Plasminogen activators and NMDA after brain injury

DESCRIPTION (provided by applicant): Traumatic injury is the leading cause of death for infants and children and mortality is greatly increased in the presence of head injury. While the effects of brain injury have been extensively investigated in the adult, less is known in the newborn/infant. Cerebral blood flow (CBF) falls and pial arteries constrict more in newborn versus juvenile pigs after fluid percussion brain injury (FPI), supporting the idea that the newborn is more sensitive to traumatic vascular brain injury. Activation of the N-methyl-D-aspartate (NMDA) glutamatergic receptor subtype is thought to play a crucial role in excitotoxic neuronal cell death. Urokinase and tissue plasminogen activator (uPA and tPA) are serine proteases whose contributions to the regulation of cerebral hemodynamics are not well characterized. tPA may contribute to excitoxic neuronal cell death via enhancement of NMDA receptor mediated signaling. The term neurovascular unit (NVU) focuses attention on the interactions between cerebral blood vessels and neurons. The tPA treatment paradox could relate to vasodilation. Plasminogen activator vascular activity is mediated by the low density lipoprotein receptor (LRP). We show tPA and uPA elicit vasodilation at pathophysiologic concentrations while administration of tPA and uPA inhibitors partially prevented FPI induced inhibition of NMDA dilation and reductions in pial artery diameter in an age dependent manner. We propose that plasminogen activators change the MAPK isoform expression/activation profile in an LRP dependent process to elicit both initial hyperemia and NMDA impairment of cerebral hemodynamics producing marked histopathology post insult in the newborn but only NMDA impairment of cerebral hemodynamics and modest histopathology in the juvenile. The hypothesis is that plasminogen activator release following FPI produces hyperemia and inhibits NMDA receptor mediated effects on CBF in an age dependent manner leading to impaired cerebral hemodynamics and edema followed by neuronal cell loss. The tPA therapeutic treatment paradox may relate to changes in the MAPK isoform expression profile. Three specific aims will be investigated in newborn and juvenile pigs: 1. Characterize the relationship between the plasminogen activators and NMDA receptor activation in cerebral hemodynamics following FPI as a function of age. 2. Investigate the role of MAPK isoforms and LRP as the mechanism by which plasminogen activators and NMDA receptor activation control cerebral hemodynamics following FPI as a function of age;Changes in the MAPK isoform expression profile result in impaired cerebral hemodyanamics and neuron cell loss post insult. And 3. Determine the association between plasminogen activator and NMDA receptor induced impairment of cerebral hemodynamics and histopathology following FPI as a function of age. Immunohistochemistry, detection of plasminogen activator and MAPK expression, and CBF determination by radiolabled microspheres will be performed.